Mitochondrial Function and Multiomics in Aging-related Disease: Identifying Novel Biomarkers and Causal Relationships

Mitochondria play an essential role in cellular function and impact human health through varied mechanisms,
including energy metabolism, cell signaling, and apoptosis. We have previously demonstrated that mitochondrial
DNA copy number (mtDNA-CN), which reflects some aspects of mitochondrial function, can readily be measured
from DNA extracted from buffy coat, and is associated with various aging-related diseases and phenotypes. The
recent availability of whole-genome sequence (WGS) data in large biobanks, along with plasma metabolomics
and proteomics, vastly expands the ability to assess mitochondrial function in large sample sizes. Specifically,
we hypothesize that a comprehensive assessment of mtDNA variation, including mtDNA-CN, homoplasmy
(inherited variation), and heteroplasmy (somatic variation) in 680,000 subjects, combined with
metabolomics/proteomics, will identify novel causal associations between mitochondrial function and all-cause
mortality, CVD, and frailty. To test this hypothesis we will first identify plasma metabolites/proteins associated
with mitochondrial function. We focus on identifying metabolites/proteins associated with mtDNA sequence
variation, leveraging the concept of Mendelian randomization (MR) to avoid confounding. We will study omics
measured in up to 300,000 UK Biobank (UKB) participants, with validation in TOPMed samples (n~25,000), and
compare associations with mtDNA sequence variation to those for mtDNA-CN. Biomarkers associated with
mtDNA genetic variation and not mtDNA-CN will be considered orthogonal biomarkers. Second, we will stablish
phenotypic associations between biomarkers of mitochondrial function and aging-related diseases. We will
determine the association of mitochondrial function biomarker with all-cause mortality, CVD, CVD risk factors,
and frailty in UKB samples, with validation in TOPMed samples. We will also explore multivariable models looking
for potential interactions between the various measures of mitochondrial function. Finally, we will discriminate
causal from non-causal associations of mitochondrial function biomarkers and aging-related disease. We will
identify instrument variables for MR by conducting GWAS of nuclear variants with mtDNA-CN, heteroplasmy,
and mtDNA-associated metabolites/proteins. We will use MR to determine causality and causal mediation
analysis to determine mediated proportions. We will then use systems biology approaches to identify the relevant
gene(s) at each locus and map putative functional variants for experimental validation. We will characterize the
identified genes by assessing mitochondrial function (e.g., cellular respiration, glycolytic flux) and quantity
(nucleoid density, mass). In sum, this proposal will leverage the combination of genetic variation, both inherited
and somatic, in conjunction with mtDNA-CN, metabolomics, and proteomics, is a highly innovative approach that
will identify readily measurable biomarkers of mitochondrial function. By combining MR with functional validation,
we will identify causal genes, identifying therapeutic targets for aging-related diseases exacerbated by
mitochondrial deficiency, and serve as potential readouts for testing molecular therapies.

Public health relevance
Mitochondria play a key role in human health, and loss of mitochondrial function has been associated with cardiovascular disease and overall mortality. We will leverage data from ~680,000 individuals to identify genes associated with mitochondrial function, providing potential therapeutic targets for aging-related diseases exacerbated by loss of mitochondrial function.